Micropeptides: Biogenesis and Function

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Micropeptides: Biogenesis and Function
organized by Drs. Ami Bhatt, Alan Saghatelian and Stephan Wenkel. The conference will be held in Snowbird,
Utah from April 6-9, 2022.
Historically, microproteins have been largely overlooked until the past decade. It has been found that these
micropeptides now appear to play interesting and sometimes outsized roles in biological regulation across the
tree of life. From the peptides that are important for transcriptional regulation in plants to the bacterial small
proteins that regulate the function of multidrug efflux pumps to the micropeptides that modulate muscle
performance in mammals, science is only now discovering the wealth of biological properties of these small
proteins. This Keystone Symposia conference will bring together experimental biologists, computational
biologists, structural biologists, biochemists, microbiologists, physician scientists and technologists to share
cutting edge insights in this emerging field of interest. This will be the very first conference, to our knowledge,
that is focused solely on microproteins. Finally, this conference is anticipated to bring together a group of
scientists who do not normally have an opportunity to interact at any other meeting or forum.

Public health relevance
PROJECT NARRATIVE Microproteins have been largely overlooked until the past decade, but research is now indicating that these micropeptides influence many biological properties. From the peptides that are important for transcriptional regulation in plants to the bacterial small proteins that regulate the function of multidrug efflux pumps to the micropeptides that modulate muscle performance in mammals, science is just now discovering the wealth of biological properties of these small proteins. This conference will bring together experimental biologists, computational biologists, structural biologists, biochemists, microbiologists, physician scientists and technologists to share cutting edge insights in this emerging field.